Complex odor recognition of the main olfactory bulb

PROJECT SUMMARY
Alzheimer’s disease is characterized by accumulation of insoluble forms of amyloid- (A) in the extracellular
space and within vessel walls, aggregation of the microtubule protein tau in intracellular neurofibrillary tangles
and neuroinflammation - contributing to neuronal damage and clinical dementia. A critical barrier in treating
Alzheimer’s disease is the years to decades-long lag between initiation of disease and clinical diagnosis, when
reversal of brain pathology and recovery of neurons may at best, slow cognitive decline. Thus, it is essential to
identify the pathological processes in early disease to characterize biomarkers for diagnosis and find
interventional targets that will halt disease prior to symptoms and signs of dementia. An early phenotype of
Alzheimer’s is smell loss. Because sniff-induced gamma oscillations generated in the olfactory bulb (OB) are
directionally coupled to the hippocampus, smell loss would result in decreased hippocampal gamma
oscillations that has been postulated to lead to neurodegeneration and cognitive decline. Interestingly,
research has shown that entrainment of gamma oscillations in the hippocampus through activation of visual or
auditory cortex recruits both neuronal and glial responses to attenuate Alzheimer’s-disease-associated
pathology. Taken together these studies raise the question whether activation of gamma oscillations in the OB-
hippocampus axis attenuates Alzheimer’s-disease-associated pathology. We hypothesize that that gamma
frequency optogenetic stimulation of olfactory bulb input will alleviate the deficit in learning and
memory and loss of smell in 5xFAD mice, an animal model of familial Alzheimer’s disease.
To test this hypothesis, we will determine whether optogenetic entrainment of the input to the olfactory bulb
results in decreased neuroinflammation and improved cognitive function: (Aim 1): Test whether optogenetic
stimulation of olfactory input to the olfactory bulb results in improved learning and memory in the go-no go
odorant discrimination task in 5xFAD-hChR2V mice. (Aim 2): Test whether optogenetic stimulation of olfactory
input to the olfactory bulb in 5xFAD-hChR2V mice elicits decreased microglial activation, phosphorylated tau
and amyloid plaque deposition in the olfactory bulb/hippocampal circuit.
The experiments proposed here are within the scope of the parent grant DC000566 that investigates
through combined behavioral, two photon imaging and electrophysiological recording olfactory
function in mice and are significant since they will identify pathogenic mechanisms that occur in early
AD prior to the onset of clinical dementia that can provide early therapeutic targets to slow or halt
progression of AD.

Public health relevance
PROJECT NARRATIVE Olfactory dysfunction is an early symptom of Alzheimer's disease (AD) that occurs prior to the symptoms and signs of dementia. The proposed studies herein will elucidate whether optogenetic light activation of the olfactory bulb slows cognitive decline in an animal model of Alzheimer's (the 5xFAD mouse). Findings will be significant since they may provide a target for early AD therapies.